Investigating the role of a novel fungal RNA in intestinal innate immunity and inflammation

The human gut is home to a complex ecosystem of microbes, including fungi. While bacterial contributions to
gut health and disease have been extensively studied, the role of the fungal community (mycobiota), remains
largely unexplored. Emerging evidence suggests that disruptions in the fungal community (fungal dysbiosis),
play a significant role in inflammatory diseases such as inflammatory bowel disease (IBD). Despite this, little is
known about how gut fungi interact with the host immune system during health and disease. Our recent research
has identified a novel fungal RNA molecule, termed fungal stimulatory RNA (fsRNA), which activates the
intestinal immune responses. Unlike other non-stimulatory eukaryotic RNAs, fsRNA triggers immune responses,
suggesting an RNA-based communication mechanism between fungi and the host immune system. The goal of
this proposal is to investigate the role of fsRNA in modulating intestinal innate immune responses and
contributing to inflammation. By using interdisciplinary approaches such as fungal genetic engineering, long-
read RNA sequencing, advanced imaging, and in vivo disease models, we aim to uncover the mechanisms of
fsRNA-triggered immunity and its impact on gut inflammation. Understanding the interactions between fungal
RNA and the immune system could reveal a novel mode of fungal-host communication and highlight new
therapeutic targets for treating IBD. This research is expected to expand our knowledge of host-mycobiota
interactions by shifting the focus from traditional protein-based virulence factors to RNA-based immune
modulation. Ultimately, the findings could lead to innovative therapeutic approaches for managing inflammatory
diseases and potentially open up new avenues for the development of RNA-based therapies.

Public health relevance
Understanding host and microbial interaction is central to advancing new therapies, including treatments for inflammatory bowel diseases. Using interdisciplinary approaches, we will investigate how specific gut fungi influence our intestinal inflammatory immunity, a process termed fsRNA-triggered innate immunity. Our research promises to revolutionize treatments for inflammation for gut health solutions.